MICROFLUIDIC SAMPLE HANDLING &FLOW CYTOMETRY: DRUG DISCOVERY

We have met periodically to consider the potential value of biomaterials and bioengineeeing for drug discovery and high throughput screening by flow cytometry. These interactions led to the formation of a bioengineering consortium and an application for a biomedical research partnership (PAS 99-010).